Tuberculosis: The Host-Pathogen Interface

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Tuberculosis: The Host-Pathogen Interface,
organized by Drs. Marcel Behr, Lalita Ramakrishnan and Kevin Urdahl. The conference will be held in Keystone,
Colorado from March 24-27, 2024.
Each year, tuberculosis afflicts millions of people around the globe, yet many of these individuals are thought to
clear their infections without manifesting disease symptoms. Therefore, understanding why only a fraction of
infected individuals are susceptible to disease represents a critical gap in knowledge that affects a sizeable
patient population. The Mycobacterium tuberculosis lifecycle involves entry, survival, proliferation and exit, and
spans minutes to months or even years. At each step, host opportunities to thwart and eliminate infection can
be overcome by bacterial countermeasures. Therefore, this Keystone Symposia conference was developed to
bring together researchers who study the tuberculosis host-pathogen interface, at the scale of molecules,
individual cells and the cellular aggregates, or granulomas, which are the hallmark structures of tuberculosis.
This program will include sessions that will cover research on nontuberculous mycobacteria and other pathogens
with similar “lifestyle” aspects to M. tuberculosis and will include studies on host processes in other contexts in
order for participants to achieve a more complete understanding of tuberculosis and related pathogens. Finally,
the program will feature emerging tools and methodologies for interrogating the tuberculosis host-pathogen
interface. It is anticipated that this “holistic” approach will enhance understanding of basic infection biology to
inform new strategies for global elimination of this age-old pathogen.

Public health relevance
PROJECT NARRATIVE As we emerge from the COVID pandemic, there is an urgent need for the TB research community to re- engage in scientific interactions, to exchange ideas and to establish new collaborations. As the community rethinks ways to prevent and treat TB, everything begins with a thorough understanding of the fundamental biology of TB immunopathogenesis. This Keystone Symposia conference is designed to re-invigorate progress in the tuberculosis field by creating an engaging environment to foster new ideas and networking opportunities for trainees and investigators at every career stage.